Wisconsin Alzheimer's Disease Research Center

PROJECT SUMMARY - OVERALL
The overarching goal of the renewal of the Wisconsin Alzheimer’s Disease Research Center (ADRC) is to
conduct breakthrough research on the pathobiology, preclinical biomarkers, early diagnosis, treatment, and
prevention of Alzheimer’s disease (AD) and related dementias. This goal will be accomplished by establishing a
stimulating, interdisciplinary environment for collaborative, equitable, and generalizable research that provides
invaluable clinical data, ante-mortem biospecimens, and autopsy brain tissue. Funded by NIA in 2009, the
Wisconsin ADRC will oversee eight well-integrated Cores and the Research Education Component that will
support timely, innovative research, which will: 1) characterize preclinical biomarkers of AD and their role in
predicting transition from preclinical to clinical stages of the disease; 2) investigate the neurobiology of AD; 3)
identify novel vascular and genetic risk factors, linking them to the disease pathology and clinical phenotype; 4)
incorporate contemporary biochemical and molecular techniques into clinical-pathologic cohort studies, including
multidimensional omics and next generation sequencing; and 5) participate and facilitate the missions of other
federal, state, and local agency-supported aging and dementia research programs. The overall goals of the
Center will be accomplished through coordinated activities of its eight Cores and the REC. The Administrative
Core will provide scientific leadership to the ADRC. The Clinical Core will perform standardized evaluations and
collect UDS and additional data on all research participants. It will work closely with the Outreach, Recruitment
and Engagement (ORE) and the Inclusion of Underrepresented Groups (IURG) Cores to enhance enrollment of
participants from underrepresented groups. The Data Management and Statistical (DMS) Core will continue to
meet all data management, informatics, and statistical needs and support all the PC- and web-based services
and processes. The Neuropathology Core will continue to provide neuropathologic diagnoses and process, store,
and distribute antemortem biospecimens and postmortem brain tissue to support novel research in AD. The ORE
Core will provide a broad-range of educational and community outreach programs about AD and support the
Wisconsin ADRC’ goal to recruit research volunteers, especially those from URGs into the Clinical Core and
other NIA-funded initiatives, such as ACTC, ADCS, ADNI, NCRAD and GWAS studies. The IURG Core will work
closely with the ORE and Clinical Cores to enhance recruitment and retention of URG participants into the ADRC.
The Biomarker Core will support and provide access to resources in preclinical neuroimaging and fluid
biomarkers of AD. The REC will coordinate closely with the Clinical, ORE, IURG, Neuropathology, and DMS
Cores to provide state-of-the-art, competency-based training to learners of varied backgrounds and levels of
training, including high school students, undergraduates, doctoral students, postdoctoral fellows, and early-stage
faculty in all aspects of aging & dementia research. The Care Research Core will provide novel expertise and
resources to conduct innovative studies that will enhance patient care and change clinical practice.

Public health relevance
PROJECT NARRATIVE - OVERALL The overarching scientific theme of the Wisconsin Alzheimer’s Disease Research center (ADRC) is preclinical, multimodal biomarkers of Alzheimer’s disease (AD) and their role in predicting transition from presymptomatic to clincial stages of the disease. There is convincing evidence that AD pathology starts several decades before the onset of symptoms, and discovery of biomarkers that represent asymptomatic stages of the disease will lead to early diagnosis and effective treatments and prevention strategies for the disease. Identifying asymptomatic at risk individuals during preclinical stages of AD will allow initiation of therapies that will either slow or, preferably stop the progression of the disease. Breakthrough research conducted at the Wisconsin ADRC has made seminal contributions to the field of AD research and has the potential to eventually find a cure for AD. This will have a great impact on patients and their families and will reduce the enormous societal costs and burden associated with this devastating disease.